Training and Teaching for Transforming Big Data to Knowledge

PROJECT SUMMARY There are limited formal opportunities for biomedical and health science trainees to acquire essential data science skills. Along with the growth in biomedical and health data, there will be a need for researchers to develop approaches for leveraging them to discover and validate hypotheses. The Training and Teaching for Transforming Big Data to Knowledge (T3BD2K) Initiative will address these needs by: (1) Developing a ten­week short course to teach pragmatic data science skills? and (2) Coordinating data science education across training programs in Rhode Island. The T3BD2K Initiative will directly impact all currently funded NIH training programs and be developed synergistically with the Data Science Initiative at Brown University. A significant artifact of this training program will be a publicly available curriculum and associated teaching materials aimed at biomedical trainees for providing pragmatic training in biomedical informatics and data science (e.g., biostatistics, computer science, and applied mathematics), alongside fundamental principles of team science, that could be utilized by students nationally. All course materials will be made available using a Creative Commons CC­BY­4.0 license, and made available through publicly accessible systems (GitBooks and GitHub). Additionally, all lectures will be video captured, with the goal of transitioning a traditional format mode for teaching the course to a “flipped” classroom. The course will culminate in a symposium that showcases participants applications of data science in biomedical and health contexts, with project abstracts, posters, and oral presentations being made available through a publicly accessible data repository that is maintained by Brown University (the Brown Digital Repository [BDR]). The overall success of the T3BD2K Initiative will be poised to transform pragmatic data science training and teaching in Rhode Island, with the potential to inform biomedical data scientist training nationally.

Public health relevance
PROJECT NARRATIVE The Training and Teaching for Transforming Big Data to Knowledge (T3BD2K) Initiative will address an acute need for developing educational opportunities that incorporate pragmatic research experiences for the biomedical researchers of tomorrow to develop skills to best leverage electronic biological and health data, including those from personal genomes, electronic health record systems, disease registries, and claims databases.